Core D: Administration Core.

PROJECT SUMMARY/ABSTRACT
The Administrative Core will provide executive oversight and administrative support for all of the projects and
cores that comprise the Genomics of Acute Myeloid Leukemia (GAML) Program Project Grant. The goal of the
Administrative Core is to monitor the activities of all of the program components, to comply with all local and
federal guideline for grant administration, and to facilitate communication and collaboration among the program
members and the External Advisory Board. Accordingly, the specific aims of the Administrative Core are as
follows:
Specific Aim/Core Service 1: We will facilitate communication and collaboration among investigators.
Specific Aim/Core Service 2: We will provide administrative oversight and support for all projects and cores.
Specific Aim/Core Service 3: We will provide budgetary management for all projects and cores.
Specific Aim/Core Service 4: We will coordinate all GAML PPG-related meetings, including those with
External Advisory Board members.

Public health relevance
Project Narrative The Administration Core will provide executive oversight and administrative support for all of the projects and cores that comprise the PPG. The goal of the Administration Core is to monitor the activities of all of the program components, to comply with all local and federal guideline for grant administration, and to facilitate communication and collaboration among the program members.